Prevention of Suicide in Veterans Through Brief Intervention and Contact (VA-BIC)

BACKGROUND: Despite work by the Department of Veterans Affairs (VA) to implement a package of suicide
prevention strategies, suicide remains an ongoing problem among Veterans, particularly during the three
months following psychiatric hospitalization. [Current evidence suggests that some of the most important
contributing factors to post-hospitalization suicide risk include poor social connectedness and engagement in
care in the post-discharge period. In response, we developed a promising suicide prevention strategy called
Prevention of suicide: Education, Awareness, Connection, and Engagement (PEACE), which combines a
mobile health (mHealth) technology with a manual-based intervention to increase connectedness and
engagement in care. Our pilot data suggest that a manual-based approach to improving engagement in care
holds great promise in mitigating suicide risk, but could be further enhanced through the addition of a mHealth
strategy to increase social connectedness. Therefore, the next appropriate step is to perform a clinical trial in
order to clarify whether combining these two approaches together is an effective suicide prevention strategy.]
OBJECTIVES: The long-term goal is for the candidate, Dr. Natalie Riblet, to become an independent clinical
researcher focused on developing, testing, and improving interventions to prevent suicide. Her overall
objective for this five-year career development program is to gain the education, mentorship, and research
experience needed to launch her independent clinical research career. Her short-term goal is to obtain the
necessary skills in: [(1) designing and adapting clinical interventions; (2) designing, conducting, and managing
clinical trials]; and (3) performing clinical research in patients at high risk for suicide. Her research objectives
align with these goals. Dr. Riblet’s proposed research project tests the efficacy of [PEACE] in decreasing
suicide risk following psychiatric hospitalization. Her central hypothesis is that [PEACE] plus standard
psychiatric hospital discharge care [(TAU)] leads to a greater reduction in suicidal ideation after psychiatric
hospitalization compared to [TAU] alone. A secondary hypothesis is that [PEACE] exerts its anti-suicidal effect
by [improving social connectedness and engagement in care.] She will submit a merit award proposal in the
last two years of the award period. If the results of this proposal are positive, Dr. Riblet’s merit award proposal
will focus on conducting a multi-site trial of [PEACE], making further improvements to [PEACE], and/or
developing an alternative intervention that better addresses suicide risk.
METHODS: A randomized controlled trial of [PEACE] will be carried out in Veterans who are psychiatrically
hospitalized at the [White River Junction VA Medical Center.] Eligible patients will be recruited over a period of
four years and will be randomized to [PEACE plus TAU or TAU alone.] Patients will be followed for a period of
six months. Outcome data will be collected at baseline and at one-, three-, and six-month follow-up time
points. A generalized linear mixed model will be used to determine whether [PEACE] leads to significant
improvements in suicidal ideation. A structural equation model will be used to determine whether social
connectedness and engagement in care moderates the effect of [PEACE] on suicidal ideation. An exploratory
analysis will be conducted using time-to-event analysis to determine the effect of [PEACE] on suicide attempts.
IMPACT: The goal of the proposed career development award is to help Dr. Riblet become an independent
clinical researcher in the field of suicide prevention. This five-year award will consist of educational, research,
and mentorship components. The education components will provide Dr. Riblet with additional skills to
become skilled in conducting clinical research in Veterans at high risk for suicide. The research components
will equip Dr. Riblet with tangible skills in conducting a clinical trial of a suicide prevention strategy and these
data will be used to inform a future merit award. Dr. Riblet will also benefit from expert mentorship from
leaders in suicide prevention and clinical research.

Public health relevance
The proposed research is highly relevant to Veterans’ health because it will test a [novel intervention that addresses two key contributors to suicide risk after psychiatric hospitalization: poor social connectedness and engagement in care.] There is overwhelming evidence that one of the highest risk periods for suicide in Veterans is the three months following psychiatric hospitalization. The proposed suicide prevention strategy, [Prevention of suicide: Education, Awareness, Connection, and Engagement (PEACE), directly addresses this high-risk phase of care by coupling a mobile health intervention targeting social connectedness with a manual- based approach to support engagement in care after discharge.] This proposed research has the potential [to be highly scalable] and could have a large, positive impact on the health and well-being of Veterans by preventing suicide in Veterans who are at high risk for suicide. The proposed research is also highly relevant to the VA’s top clinical priority, namely suicide prevention in Veterans.